Pulmonary Toxicology Facility

PROJECT SUMMARY - PULMONARY TOXICOLOGY FACILITY (PTF)
The overarching goal of the Pulmonary Toxicology Facility (PTF) is to provide the facilities and expertise for
investigators to enhance the productivity and quality of their pulmonary toxicology research and to assist them
in exploring new investigative areas in asthma, pulmonary biology, inhalation toxicology, and aerosol science.
Investigators are also supported with expertise and assays to evaluate exposures to rural airborne toxicants,
asthma triggers, and microorganism-associated molecular patterns such as bacterial endotoxin and fungal
glucans in environmental epidemiology studies. The PTF is an extremely productive and highly interactive facility
that plays an indispensable role in advancing rural environmental health and the Thematic Areas, Pilot Grant
Program, and Career Enhancement Program of the EHSRC. Through rigorous and transformative research, the
PTF expands the body of knowledge on inhaled toxicants applying innovative exposure systems and
methodology. The PTF conducts studies to elucidate adverse outcome pathways for inhaled environmentally-
relevant toxicants and multipollutant mixtures. The PTF has the equipment and staff expertise to provide
investigators with validated methods and authenticated biological reagents for addressing novel hypotheses
regarding pulmonary exposures, lung biology, and biological response profiles. The PTF provides services free
of charge to recipients of EHSRC pilot grants and Associate Members receiving salary support from the Career
Enhancement Program. Other EHSRC Members, NIEHS intramural researchers, and members of NIEHS-
funded centers at other institutions receive discounted rates. The institutional commitment to the facility is
spectacular, with a recent $4.3 M facility renovation plus $500,000 for new instrumentation. In the current cycle,
the PTF has served 78 investigators on 87 projects including in vitro and in vivo toxicology studies and
environmental epidemiology cohort studies. Six specific aims will be addressed in the proposed scope of work:
Aim 1) Provide expertise and facilities for the use of animal models to elucidate adverse outcome pathways of
xenobiotics or to test novel inhalation therapies; Aim 2) Design and perform inhalation exposure studies to groups
of laboratory animals under rigidly controlled exposure conditions; Aim 3) Assess biomarkers and sensitive
physiologic endpoints to identify biological response profiles, low-dose functional changes, and susceptibility
factors; Aim 4) Provide high-content in vitro studies using tri-culture lung cells exposed at the air-liquid interface;
Aim 5) Perform exposure assessment of endotoxins, glucans, allergens, and metagenomics of microbial
communities in support of epidemiologic studies of environmental lung diseases; and Aim 6) Facilitate pre-
doctoral, post-doctoral and EHSRC member training. The vast array of services provided by the PTF are crucial
to meeting EHSRC goals and advancing NIEHS priorities as articulated in their strategic plan.